Project 4: Pyrolytic conversion of PAHs in contaminated sediments into char to eliminate toxicity and enhance soil fertility

Project Summary
There is a pressing need for more reliable and cost-effective remediation of contaminated soils and sediments
at Superfund sites to mitigate exposure and protect public health. This project will develop a sustainable
thermal remediation technology to rapidly and reliably treat soils contaminated with such priority pollutants,
including activated PAHs byproducts of environmental transformations. Similar to all other thermal remediation
technologies, high energy requirements are a major cost driver that hinders its scalability and broad
application. Thus, significantly decreasing energy requirements for thermal treatment is a critical goal (and
anticipated benefit) of this project. During the current funding cycle, we made significant novel scientific
contributions: (a) Discovery of a new pyrolytic degradation pathway that degrades PAH by anoxic heating and
eventually converts them to a stable and non-toxic (char-like) carbonaceous residue, which is a safe treatment
endpoint. (b) Recognition of the importance of soil components like clays, which can catalyze PAH
decomposition reactions, apparently facilitated by π-cation interactions between PAHs with transition metals.
(c) Use of a combined mathematical and experimental approach to analyze soil behavior and soil-contaminant
interactions during pyrolytic treatment, and derive the kinetics of decomposition reactions. This framework
allows us to study potential tradeoffs between PAH degradation efficiency, energy requirements, and residual
toxicity of treated soils due to toxic byproducts potentially forming at low temperatures. Thus, our Specific Aims
are to: 1. Understand and exploit the catalytic effect of natural clays with common transition metals (e.g., Fe,
Cu) to accelerate the pyrolytic degradation of PAHs, detoxify the contaminated soils and decrease the required
treatment temperature, time, and energy. 2. Apply molecular modeling with density-function theory to advance
molecular-level understanding of PAH proximal adsorption and degradation mechanisms on catalytic sites, and
characterize pathways and byproducts to guide safe application. 3. Develop a process model for designing and
optimizing pyrolysis reactors. Our hypothesis is that pyrolytic treatment of contaminated soils under carefully
selected conditions will consistently achieve regulatory compliance and completely eliminate toxicity while
recovering soil fertility to facilitate ecosystem restoration. Furthermore, clays enriched with common transition
metals will catalyze pyrolytic degradation of PAHs, and decrease the required temperature and contact time to
significantly lower the energy requirements. Overall, this project will advance molecular-level understanding of
PAH degradation in pyro-catalytic treatment systems and enable predictive understanding of contaminant/soil
interactions and reaction mechanisms. Thus, this Project will inform the design of thermal treatment processes
with lower energy requirements, higher throughput capacity, and wider applicability.

Public health relevance
Project Narrative In this project, studies are proposed to test the hypothesis that pyrolytic treatment of contaminated soils under carefully selected conditions will consistently achieve regulatory compliance and completely eliminate toxicity while recovering soil fertility to facilitate ecosystem restoration. This project will combine experimental techniques pioneered by our team with density-function theory to advance molecular-level understanding of degradation mechanisms to advance predictive understanding of contaminant/soil interactions and pyrolysis reaction mechanisms to inform the design of thermal treatment processes with lower energy requirements, higher throughput capacity, and wider applicability.